Bioenergetic Contributions to Tau Phosphorylation in Aging and Alzheimer Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s Disease (AD) is the most common form of dementia and affects nearly 6.9 million older adults in
the United States. It is pathologically defined by accumulation of amyloid plaques and neurofibrillary tau
tangles (NFTs) within the brain, leading to cytotoxicity and neurodegeneration. The progression of these
biomarkers begins nearly a decade before onset of cognitive impairment. While many factors contribute to AD
development, a significant risk for AD that can begin early in life includes metabolic impairment and
mitochondrial dysfunction. Mitochondrial dysfunction has been observed in many different models of AD, but
the mechanism of its contribution to AD is still unclear. In AD, tau protein is hyperphosphorylated and
aggregates into NFTs that regionally deposit throughout the brain; tau deposition tracks very closely with
clinical manifestation of cognitive impairment in AD patients – this emphasizes the importance of
understanding the mechanisms that drive tau phosphorylation, which are still unclear. Tau is a
microtubule-associated protein and is essential for microtubule stability within the axons of neurons; when
neurodegeneration occurs in AD, microtubules depolymerize, tau is phosphorylated, and subsequently
aggregates. Microtubule stability is an energy-dependent process. Impaired mitochondrial bioenergetics, as
have been seen in AD, might contribute to microtubule depolymerization by altering the amount of
bioavailable cellular energy, leading to neurodegeneration and tau phosphorylation. We seek to address
this knowledge gap by combining cellular and clinical measures from clinical research participants in our KU
Alzheimer’s Disease Research Center. We will leverage existing clinical data from our studies and combine it
with cellular experiments using the cytoplasmic hybrid (cybrid) neuronal cell model, which come from the same
research participants. Cybrid cell lines are generated using mitochondrial DNA (mtDNA) from our research
participants, allowing us to probe specific questions regarding the impact of mitochondrial metabolism on
cellular function. To investigate the impact of mitochondrial bioenergetics on tau phosphorylation, we will use
cybrid lines from individuals with and without AD to evaluate differences in cybrid proteomes and mitochondrial
function (Aim 1a) and alterations in mtDNA that might contribute to AD development (Aim1b). Combined, Aims
1a and 1b will provide critical knowledge regarding the mechanism behind tau phosphorylation in AD, and how
mtDNA and mitochondrial function contribute to these observations. We will then investigate relationships
between mitochondrial bioenergetics and clinically relevant measures impacted by AD, such as neuroimaging
and cognition (Aim 2). This proposal will investigate the role of mitochondrial bioenergetics in tau
phosphorylation in AD and aging, and provides a training plan that will support the applicant in developing
essential skills for a future career as a translational researcher in academia.

Public health relevance
Narrative Alzheimer’s Disease (AD) is the leading form of dementia, with increased risk implicated by metabolic impairment and mitochondrial dysfunction. AD is pathologically defined by accumulation of beta-amyloid plaques and neurofibrillary tau tangles in the brain, but the direct effect of mitochondrial dysfunction on these biomarkers is still unclear. In this proposal, we will combine cellular measures and existing clinical data from the same clinical research participants to understand the role of mitochondrial bioenergetics on tau phosphorylation in AD.